Microglia-Integrated Brain Organoids for Gaucher Disease Modeling and Therapeutic Discovery

Summary
Neuronopathic Gaucher disease (nGD) is a severe pediatric genetic disorder caused by mutations in GBA1, the
gene that codes for lysosomal acid β-glucosidase (GCase). Defective GCase impairs the degradation of
glucosylceramide (GluCer) and glucosylsphingosine (GluSph) in the central nervous system (CNS), activating
glial cells and contributing to neuroinflammation. The prevalence of GD is 1 in 500 among Ashkenazi Jews and
1 in 60,000 in the general population. Approximately 10% of GD patients in the US and Europe, and around 75%
in Asian countries, are diagnosed with nGD. Patients with nGD often manifest early in life with high mortality.
Emerging evidence implicates microglial dysfunction in the pathogenesis of various neurodegenerative disorders,
including nGD, but the mechanisms by which GCase deficiency leads to microglial activation and
neurodegeneration in nGD remain largely unknown. Current enzyme replacement therapy (ERT) and substrate
reduction therapy (SRT) are ineffective for CNS involvement, and their safety for newborns is not well understood.
GD is a hereditary lysosomal storage disorder that is included in newborn screening programs, allowing for early
detection and timely intervention. Traditional models, including 2D cultures fail to replicate the complexity of
human brain tissues. Utilizing induced pluripotent stem cells (iPSCs) derived from nGD patients, we have
successfully developed nGD midbrain-like organoids (MLOs) model. These nGD organoid models exhibit
midbrain characteristics and nGD-specific phenotypes, such as GCase deficiency and GluSph accumulation,
providing a model system for studying nGD and a platform for drug evaluation. Furthermore, we have advanced
MLOs by incorporating microglia to create microglia-containing MLOs (mcMLOs). Microglial differentiation was
achieved by inducing the homeostatic transcription factor PU.1 in re-engineered iPSCs within a neural
differentiation environment, leading to the formation of mcMLOs. In GD, GluCer and GluSph accumulation
activates microglia, increasing cytokine release and inflammation via the C5a/C5aR1 pathway. We hypothesize
that microglia within mcMLOs profoundly influence nGD-relevant phenotypes, including microglial activation, and
that the complement C5a/C5a receptor system plays a role in exacerbating neuroinflammation. Specifically
blocking C5aR1 signaling in GCase-deficient microglia may represent a therapeutic target to prevent microglia-
mediated inflammation and neurodegeneration in nGD. To test this hypothesis, in Aim 1, we will generate nGD
mcMLOs to investigate the impact of nGD microglia in MLO growth and disease phenotypes, and to evaluate
therapeutic effects on this nGD mcMLO model. In Aim 2, we will determine the role of the microglial C5a/C5aR1
pathway in nGD and assess C5aR1 inhibition as a therapeutic approach. This advanced nGD mcMLO model
offers a unique, physiologically relevant platform using patient iPSC-derived organoids, enabling mechanistic
studies and the development of novel therapies for nGD.

Public health relevance
Narrative Neuronopathic Gaucher disease is an inherited lysosomal storage disorder that affects the brain, leading to early death with no effective treatment currently available. This application seeks to develop a human mini-brain model to simulate the disease in a physiologically relevant system. The new model will help identify therapeutic targets and accelerate drug discovery for Gaucher disease, as well as other neurological disorders.